GENETIC LINKAGE STUDIES IN NEUROLOGICAL DISORDERS

Following the detection of chromosomal linkage of genetic neurological diseases, closer genetic markers are determined. Closely linked DNA polymorphisms provide and initiation point for chromosome walking, jumping, and other methods of physical DNA analysis.